Cognitive Rehabilitation for Gulf War Illness

DESCRIPTION (provided by applicant): Gulf War illness (GWI) is a complex multi-symptom illness which causes as much disability as other major medical diseases such as cancer and chronic heart failure. Previous clinical trials (i.e. cognitive behavioral therapy and graded exercise) for GWI have sought to improve disability by increasing activity regardless of symptom presentation. These previous trials for GWI have shown limited efficacy and poor adherence. An innovative treatment approach is to target a specific component of GWI, namely problem-solving ability, known to be associated with disability. Impairment in problem-solving ability affects over 70% of Gulf War Veterans (GWV) with GWI and is prospectively related to 1.5 times greater risk of disability. This impairment is also related to poorer adherence to medical regimes, making it difficult for GWV to manage other aspects of GWI. Thus, rehabilitation of problem-solving deficits is a critical target to treat a complicated syndrome like GWI. Despite this, there are no established treatments to compensate for problem-solving deficits among GWV. We are proposing to treat the problem-solving deficits of GWI using a state-of-the-art evidence-based approach to cognitive rehabilitation, Problem-Solving Therapy. Problem-Solving Therapy teaches patients skills to overcome factors impacting problem-solving. Because Problem-Solving Therapy teaches patients strategies to address real-life problems it leads to reductions in disability in other populations. This is the first trial of cognitive rehabilitation therapy for GWI. We propose a mult-site randomized controlled trial of telephone-delivered Problem-Solving Therapy versus telephone-delivered Health Education. We will use a 12 session established Problem-Solving Therapy intervention with a structured five step sequential approach to teaching problem-solving. Disability will be measured by the overall composite score from the World Health Organization Disability Assessment Schedule 2.0 which reflects two dimensions of disability: activity limitations and participation restrictions. In order to increase the representativeness of our sample, we will recruit 258 GWV from three VA sites: New Jersey, upstate New York, and Massachusetts.

Public health relevance
PUBLIC HEALTH RELEVANCE: There are almost 700,000 Gulf War Veterans (GWV) with 25-30% suffering from a devastating multi-symptom illness coined Gulf War illness (GWI). Over 90% of GWV with GWI report significant activity limitations and over 70% report chronic cognitive problems consistent with problem-solving deficits. Problem-solving is considered the most complex of cognitive abilities and is what enables us to conduct complicated behaviors such as setting goals, sequencing and multi-tasking. As a result, studies have found that problem-solving deficits are prospectively related to a 1.5 times greater risk of disability. Despite published reports documenting these problems there are no treatments that target the problem-solving deficits of GWI. This proposal seeks to determine whether Problem-Solving Therapy, a patient-centered cognitive rehabilitation therapy, can reduce disability by compensating for problem-solving deficits.